IEEE Medical Imaging Conference

? DESCRIPTION (provided by applicant): Funding is requested to support graduate student and post-doctoral trainees at the 2015 IEEE Medical Imaging Conference, which is held jointly with the Nuclear Science Symposium. This annual international conference is the largest and most important meeting dedicated to radiotracer based medical imaging methods, particularly positron emission tomography (PET) and single photon emission computed tomography (SPECT). Additional topics of interest include development of other tomographic modalities such as novel CT techniques and multimodality imaging such as PET/CT and PET/MR. The emphasis is on detectors, imaging systems and algorithms for image reconstruction and image quantitation. At the most recent meeting in 2013 in Seoul, over 600 papers were presented within the Medical Image Conference and total attendance was 2096 with at least half of the attendees declaring the Medical Imaging Conference to be their primary interest. This grant will provide twenty graduate students and post-doctoral trainees with $500 each towards conference registration and accommodations.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project will provide financial assistance to twenty graduate students and post-doctoral fellows to attend the 2015 IEEE Medical Imaging Conference. This will advance the training of the next generation of scientists and engineers in the field, allowing them to refine and develop new methods for medical imaging. These methods will in turn allow for better diagnosis and monitoring of disease and thereby improve public health.